Molecular Regulation of Mitochondrial Permeability Transition and its Role in Regulated Necrosis

Project Summary/Abstract
Myocardial infarction (MI) and its consequent long term recovery constitutes a majority of heart disease in the
United States.1 While the return of blood flow to the heart by reperfusion can be lifesaving, it also induces
additional cardiomyocyte death.2,3 Currently, there is no therapeutic intervention that serves as a preventative
against cardiomyocyte cell death during ischemia-reperfusion (I/R) injury.17 Thus, new pharmacological agents
need to be identified. The long-term objective of this proposal is to reduce cardiomyocyte loss during I/R
injury to reduce overall mortality and diminish the onset of heart failure following MI. To accomplish this
goal, we are investigating two forms of cell death: mitochondrial permeability transition pore (MPTP)-
dependent necrosis and ferroptosis, which contribute to ischemia reperfusion (I/R) injury.5,6 During MPTP-
dependent necrosis, lethal amounts of radical oxygen species (ROS) and calcium (Ca2+) are thought to open
an inner mitochondrial pore known as the MPTP in an unknown mechanism, which causes a loss of
mitochondrial membrane potential resulting in myocyte necrotic death.7,8,9,10 Alternatively, in ferroptosis, excess
iron (Fe2+) within mitochondria generates ROS which dysregulates lipid membranes in a process known as
lipid peroxidation (LIPOX).11,12,13 In previous studies, individual pharmacological inhibition of both mechanisms
demonstrated a promising reduction of infarct size in mice.14,15 Unfortunately, clinical trials targeting the MPTP-
dependent pathway were not successful in humans, suggestive that cell death during I/R injury is more
complex than anticipated.16 Therefore, our research strategy will address if dually targeting these mechanisms
simultaneously can further reduce infarct size post I/R injury. Our preliminary data suggests that pathway
initiation depends on ROS concentration and Ca2+ availability, as low concentrations of ROS are able to
sensitize Ca2+-dependent MPTP opening, whereas high ROS levels can lead to mitochondrial dysfunction via
LIPOX. We also determined that targeting both pathways in vitro was additively protective against ROS-
induced cell death, achieved by treating ferroptosis inhibitor ferrostatin-1 on a genetic knock-out cell line of
MPTP regulator cyclophilin D (CypD). Therefore, we hypothesize that dual inhibition of MPTP-dependent
necrosis and ferroptosis pathways will be additively protective against myocardial I/R injury. In Aim 1,
we will challenge isolated heart mitochondria with I/R-relevant insults such as Ca2+, Fe2+, or ROS to
mechanistically examine pathway induction. In Aim 2, we will therapeutically target both MPTP-dependent
necrosis and ferroptosis pathways using both pharmaceutical and genetic strategies. We will use MPTP
inhibitor cyclosporine A and LIPOX inhibitor ferrostatin-1 in combination against I/R, as well as perform adeno-
associated viral (AAV) overexpression of anti-ferroptotic antioxidant GPX4 on genetic models of CypD null
mice to recapitulate the pharmaceutical strategy. With this approach, we aim to accomplish the mission of
the National heart, lung, and blood (HLBS) institute to prevent cardiomyocyte (CM) death during I/R injury.

Public health relevance
Project Narrative This study attempts to enhance the efficiency of reperfusion treatment which, while overall beneficial against myocardial infarction, unfortunately contributes to cell death within the heart. Our research strategy plans to simultaneously target two main forms of death that occur during reperfusion injury, known as MPTP-dependent necrosis and ferroptosis. Our efforts to inhibit these harmful pathways for additive protection may enhance our knowledge of the cross-talk between cell death mechanisms at play during a heart attack, as well as potentially generate a novel therapeutic targeting approach that will improve heart health and ultimately lengthen life.